Center for Research, Innovation and Training in Reproduction and Infertility

PROJECT SUMMARY/ABSTRACT
In the U.S., about 12% of women have impaired fecundity and 7% of couples have infertility. In women, the
leading causes are increasing age, ovulatory disorders, endometriosis, and tubal factor, and in couples, about
1/3 of infertility is due to female factors, 1/3 to male factors, and 1/3 to both. As mechanisms underlying the
causes of infertility are largely wanting, treatments are mostly empiric. Infertile women who conceive
spontaneously or with fertility therapies are at increased risk of adverse pregnancy outcomes due mainly to
implantation and placenta disorders, with life-long effects on the health of children and adults born from these
pregnancies. Thus, understanding mechanisms underlying reproductive success and compromise at the
genomic, molecular, and cellular levels is critical to fertility and the health and well-being of this and future
generations. Moreover, building a sustainable pipeline of junior investigators in this field and engaging
investigators from multiple disciplines with diverse expertise are essential components to unravel the
complexities of successful reproduction with translation to improving reproductive health more broadly. These
are core principles of our NIH National Center for Translational Research in Reproduction and Infertility
(NCTRI) at the University of California San Francisco (UCSF), funded since 2007 and for which this renewal
proposal is submitted. The Specific Aims of our renewal application (overall) are:
1. to advance research in reproductive science and medicine through transdisciplinary collaboration
and scientific and technologic innovation with the goal of improving human reproductive health and fertility
2. to serve as a national resource to inspire, mentor and train students, fellows, and junior scientists in
reproduction and infertility research and to nurture their career development long-term
3. to communicate and be a national resource regarding the importance of reproductive research and
its relevance to reproductive health and fertility for the public, health care professionals, and patients
Our NCTRI Center for Research, Innovation and Training in Reproduction and Infertility at UCSF has 4
projects led by an experienced team of investigators/mentors and brings together expertise in clinical medicine,
basic and translational science, precision medicine, genomics/eipgenomics, and advanced technologies
focused on reproductive biology, oocyte aging, implantation, and placental development. Moreover, it provides
a rich environment for trainees and outreach to the community about innovations in reproductive science and
medicine. Our projects use advanced technologies and “omics” approaches, animal models and human tissues
and cells, and integrate well-annotated, relevant human phenotypic and clinical data to inform our studies. Our
immediate goals are to determine epigenetic regulation of processes resulting in successful reproduction or
infertility. Our long-term goals are to develop diagnostics and targeted therapies to alleviate infertility and poor
reproductive outcomes and enhance the well-being of those with infertility and reproductive compromise.

Public health relevance
PROJECT NARRATIVE About 12% of reproductive aged women of all marital statuses in the US have impaired fecundity - with increasing age, ovulatory disorders, endometriosis, and tubal factor as leading causes. Those who conceive spontaneously or with fertility therapies are at increased risk of adverse pregnancy outcomes due mainly to implantation and placenta disorders. Our Center for Research, Innovation and Training in Reproduction and Infertility at UCSF brings together expertise in clinical medicine, basic and translational science, precision medicine, and advanced technologies focused on reproductive biology, oocyte aging, implantation, and placental development and provides a rich environment for trainees and outreach to the community about innovations in reproductive science and medicine.